MUTATIONAL SPECTRA IN HUMAN BLOOD B AND T LYMPHOCYTES

Investigates the pattern of genetic change in blood cell populations of normal humans and compares these patterns with those induced in cell culture by environmental chemicals.